Social Media Action to Reach, Teach and Educate Greater Richmond, VA, 2.0 (SMARTER-VA 2.0)

PROJECT SUMMARY
The Massey Comprehensive Cancer Center (Massey) at the Virginia Commonwealth University (VCU) seeks
an administrative supplement for its National Cancer Institute (NCI) Cancer Center Support Grant (CCSG), for
multi-channel communication campaigns for improvements in cancer education and outcomes in underserved
populations. As a leading academic medical center within the Commonwealth of Virginia, the Massey serves a
66-locality catchment area spanning central, southern, and eastern Virginia. This region is home to more than
four million residents and is characterized by communities with substantial racial, geographic, and
socioeconomic diversity that contributes to a higher overall cancer burden and significant health disparities
than reported nationally. Of those 66 localities, 26 are identified as colorectal cancer (CRC) hotspots in
Virginia. In addition, 11 of the 66 localities are listed in the top 50 in the US for high mortality among
screenable cancers including CRC. In this project, Social Media Action to Reach, Teach, and Educate greater
Richmond, Virginia, 2.0 (SMARTER-VA 2.0), Massey will direct the multi-channeled communication efforts to
the six of the 11 high mortality localities, including Colonial Heights, Essex County, Halifax County, Martinsville,
Nottoway County, and Sussex County. These localities have high CRC incidence and mortality, and higher
rates of behavioral risk factors for cancer (e.g., obesity and smoking) than Virginia and US populations.
SMARTER-VA 2.0 will focus on the general population, 30+ years old, utilizing multi-channel communication
strategies including lead-time messages for improvements in cancer education and outcomes for those with an
average risk of CRC and on-time messages for the 45 to 50 age group, who may not be aware of new CRC
screening guidelines. Massey looks to expand educational opportunities for this population to increase the
prevention, early detection, and uptake of CRC screening and address health literacy gaps toward actionable
change. Guided by the 2021-2025 Strategic Plan, MCC’s overarching focus for research, education, and
community outreach and engagement efforts will be to reduce cancer health disparities and improve
survivorship for all with priorities placed in developing innovative approaches to the prevention and treatment
of lung, gastrointestinal, breast, and prostate cancers as well as two key behavioral factors, tobacco and
obesity control.

Public health relevance
PROJECT NARRATIVE The goal of this Administrative Supplement to the Massey Comprehensive Cancer Center’s P30 Cancer Center Support Grant is to activate social media campaigns to inform and educate communities in six target localities about CRC risk and risk-appropriate screening options for those over 30 years old; connect audiences with Community Health Educators and Lay Health Advisors/Navigators through continued one- to-one online communications; and expand multi-channel communication for CRC screening education in target localities through in-person community gatherings and deploying the Massey mobile vans for strategic “pop-up” education events.